Regulation of FLT3 Signaling in Leukemia

Summary
The temporal and spatial distribution of signaling proteins is dynamically regulated by post-translational
modifications (PTMs). PTMs such as phosphorylation, ubiquitination, or lipid modification dictate protein activities
and access to substrates, thereby cellular outcomes. The precise control of signaling pathways is critical to
normal hematopoiesis and aberrant signaling leads to malignant transformation of hematopoietic stem and
progenitor cells (HSPCs). This application is based on our novel finding that FLT3 (FMS-like tyrosine kinase 3)
is palmitoylated and disrupting palmitoylation of oncogenic FLT3 mutants changes their subcellular localization,
rewires downstream signaling, and promotes leukemic progression. Internal tandem duplication within FLT3
(FLT3-ITD) is one of the most frequent mutations in acute myeloid leukemia (AML) and correlates with poor
prognosis. While wildtype FLT3 receptor tyrosine kinase is activated at the plasma membrane to transduce
PI3K/AKT and RAS/MAPK signaling, FLT3-ITD resides in the endoplasmic reticulum (ER) and triggers
constitutive STAT5 phosphorylation. Mechanisms underlying this aberrant FLT3-ITD subcellular localization or
its impact on leukemogenesis remain poorly understood. We discovered that FLT3-ITD is S-palmitoylated by the
ZDHHC6 acyltransferase. Disruption of palmitoylation redirects FLT3-ITD to the plasma membrane and rewires
its downstream signaling by activating AKT and ERK pathways in addition to STAT5. Consequently, abrogation
of FLT3-ITD palmitoylation via ZDHHC6 depletion promotes FLT3-ITD surface expression, signaling, and
increased leukemic progression in xenotransplanted mouse models. Furthermore, we demonstrate that FLT3
proteins are palmitoylated in primary human AML cells. Stabilization of FLT3-ITD palmitoylation by
pharmacological inhibition of depalmitoylation synergizes with FLT3 tyrosine kinase inhibitor (TKI) gilteritinib in
abrogating the growth of primary FLT3-ITD+ AML cells. The central goal of this grant is to define the molecular
basis underlying the regulation of oncogenic FLT3 signaling by palmitoylation and explore its physiological and
functional significance in myeloid malignancies. We propose to define roles of ZDHHC6 in FLT3-ITD
palmitoylation in vivo in mouse models of myeloproliferative neoplasm (MPN) and AML. We will also identify
depalmitoylase(s) for FLT3-ITD that modify FLT3-ITD localization, and activity using combinatorial approaches
of targeted and unbiased chemical biology, molecular biology, and genetics. Moreover, we will explore the
therapeutic potential of targeting FLT3-ITD depalmitoylation in primary human FLT3-ITD+ AMLs. We will
investigate if inhibition of FLT3-ITD depalmitoylase enhances responses to TKI using primary human AML cells
as well as patient-derived xenotransplant (PDX) models. These findings provide novel insights into lipid-
dependent compartmentalization of FLT3-ITD signaling and suggest targeting depalmitoylation as a new
therapeutic strategy to treat FLT3-ITD+ leukemias.

Public health relevance
Narrative Internal tandem duplication within FLT3 (FLT3-ITD) is frequently mutated in acute myeloid leukemia (AML) and correlates with poor prognosis. Mechanisms underlying the aberrant FLT3-ITD subcellular localization and signaling remain poorly understood. We discovered that FLT3-ITD is palmitoylated, disruption of which relocalizes FLT3-ITD and rewires FLT-ITD signaling, thus we propose to define the physiological and clinical significance of FLT3-ITD palmitoylation in AML and identify novel therapeutics to target FLT3-ITD+ AML.